Abiotic-Biotic Interfaces for Ophthalmology Symposium

ABSTRACT This proposal seeks funding to support a symposium, Abiotic-Biotic Interfaces for Ophthalmology (ABI), which will bring together recognized world experts in clinical, research, vision science, engineering, industrial and pharmaceutical communities as well as junior investigators (i.e., young faculty and those in training) to discuss the current state of ABI, ranging from bioelectronic implantable and wearable devices, to nanoscale scaffolds for stem cell and gene therapies. Given the multidisciplinary nature of this field, it is essential to bring together researchers and clinicians with varying levels of expertise across many domains related to ABI to advance the progress of this novel field, identify challenges of advancement, and develop a strategic action plan to overcome these challenges. The timing to have such a symposium to further the application of implantable and/or wearable bioengineered systems in ophthalmology is now as we focus on precision and personalized medicine and leverage the revolution in deep learning artificial intelligence algorithms. Through symposium talks, sessions, and discussions we will cover the fundamentals and also identify innovative and cutting-edge strategies and methodologies to accelerate the rate of major discoveries and development of novel therapeutics. The specific aims of this symposium are: Specific Aim 1. To bring together both established and junior investigators representing a broad range of disciplines to discuss cutting edge research in this novel field, catalyze the development of cross-disciplinary and translational approaches to advance abiotic-biotic interfaces for ophthalmology, and identify gaps in knowledge and barriers to advancement. We will identify research questions and develop an agenda to guide future research that is consistent with the objectives and interests of NEI. Specific Aim 2. Develop a junior investigator program to motivate a diverse group of students and junior investigators to pursue research careers in vision science and ophthalmologic therapeutic development, who will ultimately submit grant proposals to NEI solicitations and contribute to the scientific literature. Specific Aim 3. Develop a strategic action plan to set priorities for future studies that will encourage inter-agency collaborations (e.g., NEI, NSF, DARPA, etc.). This is critical because often certain engineering tasks are best suited to be supported by NSF or DARPA whereas the biological testing of the engineered systems lends itself to funding from NEI. Hence such inter-agency or cross-agency efforts can help leverage the funding to develop sophisticated abiotic-biotic systems

Public health relevance
NARRATIVE This meeting is the first on this topic dedicated to the broad use of implantable and/or wearable bioelectronics for ophthalmological applications. It is anticipated that the strategic action plan will significantly impact the field by greatly accelerating the translation of basic science and engineering research findings to stimulate the development of novel treatments and improve clinical practice. Key topics include visual restoration, drug and gene delivery, and sensing intraocular pressure. This meeting will foster training and development of future leaders in this emerging field and promote collaboration and exchange of knowledge and ideas among junior and established investigators.